Research and Data Analysis Core

Realizing Accelerated Progress, Investigation, Implementation, and Dissemination
in Learning Health Systems (RAPID-LHS): Research and Data Analysis Core
Building on unique and successful infrastructural elements that have been developed and established at
Vanderbilt University Medical Center and Meharry Medical College, including through the prior AHRQ/PCORI
K12 training program in LHS, the Research and Data Analysis Core (RDAC) will provide relevant services to
support the embedded research of Realizing Accelerated Progress, Investigation, Implementation, and
Dissemination in Learning Health Systems (RAPID-LHS) scientists and other partner LHS scientists.
The RDAC will comprise five components that will work closely together to support scientist needs based on
their initial needs assessment and consultation with RDAC leaders and the LHS platform. These RDAC
components are as follows:
1) Patient-Centered Outcomes Research-helping patients to make informed decisions and generating
evidence about which strategies are safe, effective, and add value to health
2) Dissemination and Implementation-improving the uptake, adaptation, delivery, and sustainability of effective
health interventions to improve health equity
3) Health Policy and Public Health-targeting policy influence to benefit all patients and improve public health
4) Stakeholder Engagement and Health Equity-ensuring that equity is addressed and that clinicians, patients,
health system administrators, community members, and organizations are engaged in all aspects of the LHS
5) Methods Advancement-facilitating the advancement and skilled use of methodological approaches and
techniques that enhance the LHS and answer clinical questions of importance to patients and other
stakeholders.
The RDAC will ensure that all necessary infrastructure is in place to support the seamless combination of
didactic and experiential training, to carry out high-quality embedded research at all stages of the project, and
to maximize each project’s impact on practices in the LHS. Projects will benefit from strong leadership and
expertise within each RDAC component. The RDAC will work to ensure that meaningful engagement of
patients, communities, and other health care stakeholders occurs at each stage of all embedded projects. All
projects will have equity-focused methods, interwoven with patient- and population-level health outcomes. The
RDAC leaders will create a roadmap for RAPID-LHS scientists’ integration into operational projects, including
long-term support in the areas of design, adaptation, measure selection, data analysis, interpretation,
sustainability, and dissemination. Finally, the RDAC will aid in implementation of findings to facilitate rapid
integration into the LHS and enhance the potential to impact health.